Infection And Disinfection Of Transmissible Spongiform E

Funding of all LCNSS research has been terminated, with the result that no experimental data has been generated during the past year. Nevertheless, the following 5 experiments (funded by the private sector or university medical centers) are either in progress or in preparation on off-campus sites: 1. Bioassay in mice of blood component infectivity in a mouse-adapted strain of variant CJD. 2. Bioassay in squirrel monkeys of blood component infectivity in human patients with either sporadic or variant Creutzfeldt-Jakob disease (CJD). 3. Inactivation of scrapie agent under incineration conditions of 600°C and 1000°C, assaying infectivity in both the ashed residue and vented flu gas. 4. Inactivation of scrapie agent using commercial technology of multiple ultra-high pressure pulsation. 5. Bioassay of total volume inoculations of serial dilutions of scrapie and CJD to determine if infectivity can be diluted to extinction. Note: the bibliography section is massively incomplete, as Pub Med has missed numerous articles published in many different journals, and there is no appropriate choice with which to complete the listing.